Exploring the Parameter Space of High Frequency Magnetic Perturbation in Manipulating Neural Excitability and Plasticity.

Project Summary/Abstract
At Magnetic Tides we developed a radically new NIBS approach, one in which subthreshold modulation of neural
excitability is brought about via oscillating magnetic fields at kilohertz frequencies. This system, referred to kTMP
(kilohertz Transcranial Magnetic Perturbation) significantly increases the range of subthreshold E-field induction,
and through modulation of the envelope of the kHz carrier frequency, can impose E-fields at physiological
relevant frequencies. In the parent grant, the initial experiments are conceived to test tolerability and efficacy of
kTMP in healthy participants, leading to behavioral experiments which focus on improving motor skills with kTMP.
The goal of the supplement research project is to test the impact of amplitude-modulated kTMP (AM-kTMP) on
a language task by targeting physiologically relevant frequencies to manipulate brain oscillations and speech
perception. These results could have important consequences for the use of AM-kTMP as an intervention in the
treatment of receptive aphasia. In parallel, the supplementee will help to test and validate our hypotheses about
the needs of motor and language rehabilitation practitioners and center with regard to our novel neurological
treatment. She will help target market segments and create value propositions with these customers. This aim
will include customer discovery and business model hypothesis testing focused on building a scalable business
model by talking to customers, partners, and competitors.
The supplementee intends to apply to medical school to become a neurosurgeon. At this stage in her career her
main goal is to gain a solid foundation in cognitive neuroscience and to be exposed as much as possible to the
neurological rehabilitation setting. By the time her appointment ends, she will have acquired the core skills
necessary to carry out an independent research project. She will also have a thorough awareness of the field of
rehabilitation on many different levels, from the clinical aspect to the broader biomedical/health technology
landscape.

Public health relevance
Project Narrative We have recently developed a new non-invasive brain stimulation (NIBS) system, kilohertz transcranial magnetic perturbation (kTMP), that opens a new experimental space for safely modulating neural excitability in targeted areas of the human brain. This project will focus on testing the impact of AM-kTMP on a language task by targeting physiologically relevant frequencies to manipulate brain oscillations and speech perception. In addition, the supplementee will conduct customer discovery interviews to test and validate our costumers' segments and our value propositions.